Fluorescence Microscopy and Cell Imaging

Project Summary/Abstract - FLUORESCENCE MICROSCOPY & CELL IMAGING SHARED RESOURCE
The UNMCCC Fluorescence Microscopy & Cell Imaging Shared Resource (Microscopy) supports basic and
translational cancer research by providing state-of-the-art instrumentation and software for quantitative, multi scale, and multi-modal fluorescence imaging, to UNMCCC members and non-member users. Faculty Director
Diane Lidke, Ph.D. (CMO) supervises the Resource, which is operated by Michael Paffett, Ph.D., a full-time
staff with broad expertise in fluorescence microscopy instrumentation. The UNMCCC Research Administration
manages the Resource, which provides access to 11 commercial instruments for fluorescence, phase or
brightfield imaging, as well as multiple software platforms for image analysis. In addition, CCC members have
access to the Super-Resolution Core, directed by Keith Lidke, Ph.D. (CMO) that houses cutting-edge and
developmental instrumentation for single molecule, super-resolution and hyperspectral imaging. The Super Resolution core is further supported by Michael Wester, Ph.D. who is an expert in single molecule image
analysis. This partnership provides UNMCCC members with technologies not available at other Cancer Centers
and the opportunity to develop new imaging and analysis approaches to specifically address outstanding
questions in cancer biology. The expense and significant expertise required to purchase, maintain and operate
such a diverse suite of instrumentation, is prohibitive for most users and underscores the value added by the
Resource. Microscopy actively facilitates and disseminates information about new cellular imaging technologies
by maintaining an up-to-date web page and by giving presentations at UNMCCC meetings and retreats.
Resource faculty and staff also contribute to multiple education activities, including courses focused on
microscopy that attract graduate students and postdocs from UNMCCC member labs. Reservations, billing and
usage are tracked through a centralized on-line system. During the previous 5-year project period, 59 UNMCCC
member laboratories from three UNMCCC Research Programs used the Resource, resulting in 67 publications.
In the previous period, UNMCCC members were responsible for 61% of total Resource usage by billing and
were supported by 132 peer-reviewed grants and 8 UNMCCC pilot projects.